Elucidating the role of circPMS1 in melanoma metastasis.

Project Summary/Abstract
Melanoma is a highly aggressive cancer from melanocytes, accounting for 1% of skin cancer cases yet causing
most skin cancer deaths. The 5-year survival for metastatic melanoma patients is below 30%. The mechanisms
driving melanoma metastasis are poorly understood, necessitating thorough investigations to enhance patient
survival rates. While targeted therapies like BRAF and MEK inhibitors can lead to initial regression, relapses
occur quickly. Immunotherapy offers lower response rates (30-50%) and substantial toxicity, highlighting the
need for novel therapeutic targets. The human genome consists of 98% non-coding regions, many of which
produce non-coding RNAs essential for cancer development, including melanoma. Circular RNAs (circRNAs),
known for their closed structure and degradation resistance, are attracting attention for their potential roles in
cancer. However, their specific functions and mechanisms in melanoma metastasis remain largely unexplored.
By analyzing RNA-sequencing data, I identified circPMS1 as the most upregulated circRNA in melanoma cells
compared to melanocytes. Using previously developed genetic tools for stable circRNA overexpression, I
assessed the oncogenic potential of circPMS1. Overexpression of circPMS1 enhanced both melanoma and
melanocyte migration and invasion in vitro. Conversely, CasRX-mediated silencing of circPMS1 resulted in
decreased migration and invasion. Furthermore, circPMS1-overexpressing cells formed more metastases in
lungs and liver when injected into NSG mice, while silencing circPMS1 significantly reduced metastasis
formation. Despite the presence of a predicted ORF and IRES, I demonstrated that circPMS1 does not translate
into a protein. This leads to my hypothesis that circPMS1 interacts with proteins that influence the metastatic
potential of melanoma cells. To investigate this, I pulled down tagged circPMS1 and identified six potential
interacting proteins via mass spectrometry. Four of these proteins (ABLIM, CAPZA2, PDLIM7, LMO7) contain
LIM domains that may bind nucleic acids and are involved in cytoskeleton rearrangement and metastasis in other
cancers. However, the effects of RNA binding on these LIM domain proteins’ biology remain unstudied. In the
light of these findings, I hypothesized that circPMS1 has pro-metastatic functions in melanoma by altering the
expression, activity, and/or localization of its protein binding partners. In the F99 phase, I will characterize these
partners and elucidate the molecular mechanism underlying circPMS1's metastatic phenotype using in vitro
assays and genetically engineered melanoma mouse models. In the K00 phase, I will examine the role of
circPMS1 in melanoma brain metastasis through in vitro and transplant models, developing therapeutic
strategies to target circPMS1 and inhibit its pro-metastatic functions. Additionally, I will identify and characterize
circRNAs associated with melanoma brain metastasis through RNA-seq, CRISPR screenings, in vitro assays,
and transplant models. The F99/K00 award will provide essential training to become an independent investigator,
enabling me to identify circRNAs as potential therapeutic targets for melanoma metastasis.

Public health relevance
Project Narrative While the survival rate of early-stage melanoma is 90%, the 5-year survival of metastatic melanoma (stage III- IV) is only 30%. The molecular mechanisms that underly melanoma metastasis are still poorly understood, in particular the role of non-coding RNA such as circular RNAs. This proposal is focused on understanding how circRNAs drive melanoma metastasis, which will allow us to open new avenues for targeted therapies in melanoma treatment.